Investigation of the effect of structural modifications of tau on assembly state and seeding

Abstract Despite significant progress in Alzheimer's disease (AD) in general and tau pathobiology in particular, there is still no effective treatment or prevention for AD or any other tauopathy. To develop such therapy, detailed knowledge of the structural biology and structure–activity relationship of tau is needed, including the way sequence alterations and post-translational modifications affect tau self-assembly into toxic oligomers and aggregates, and how these parameters impact tau seeding and toxicity. Here, we propose a systematic, detailed study of these aspects of tau pathology taking advantage of recent developments in mass- spectrometric, biochemical, and cell biology methods. We will study the effect of primary-structure alterations and post-translational modifications on tau oligomerization and aggregation in vitro and compare recombinant and in-vivo generated tau. We will then examine how all of these factors affect tau seeding using a recently developed highly sensitive biosensor cell line. To advance therapy development, we will also test the effect of assembly modulators on tau self-assembly and seeding. A unique aspect of the project is the combination of expertise of the PI and Co-I groups, which will allow obtaining insight into the structure–activity relationship of tau on multiple levels and answering currently pending questions about the complex processes governing this crucial aspect of AD.

Public health relevance
Relevance to Public Health This project addresses the essence of “Capturing Complexity in the Molecular and Cellular Mechanisms Involved in the Etiology of Alzheimer's Disease” Announcement by NIH. This is a particularly pressing goal in view of the rapid aging of the American population and the fast increasing costs of care for patients with Alzheimer's disease. We address this call by a systematic study of structural variations and molecular modulators of the protein tau, one of the main proteins responsible for the destruction of brain cells in Alzheimer's disease.